Examining the Impact of Pandemic Eviction Prevention Policies on Mortality

We propose to evaluate the effects of pandemic eviction prevention policies on individual- and area-level death rates, leveraging variation in policies over time and between locations to gain new insight into the relationship between eviction and mortality. Stagnant wages and rising rents over the last several decades have resulted in unprecedented levels of housing cost burden in the U.S. and, in turn, forced millions of renters to face the threat of eviction each year. The pandemic worsened this crisis, resulting in catastrophic job and wage loss. To prevent a surge in evictions, federal, state, and local policymakers established a range of eviction prevention policies, most notably eviction moratoria and emergency rental assistance (ERA). These policies varied across the country in how and when they were implemented, creating large exogenous variation in eviction risk. We exploit that variation to evaluate the effects of eviction on mortality and inequalities in mortality. In so doing, we provide insight into the potential for eviction prevention policies to advance health. Our project has three aims: 1) We examine the effect of eviction filings on all-cause adult mortality overall and by age, race, and sex using a unique linkage of individual eviction filing records and Census Bureau microdata. We also estimate the number of lives saved by eviction prevention policies and project mortality gains had more protective measures been comprehensively implemented. 2) We analyze the effects of eviction prevention policies on county-level mortality using a difference-and-differences framework. We analyze how the staggered lifting of eviction moratoria (2020) and disbursal of ERA (2021-22) affected all-cause, cause- specific, and age-specific adult mortality 3) We explore the lived experience of eviction prevention policies using in-depth interview data collected with renters across two distinct policy landscapes. Our project combines the strengths of multiple approaches. Our unique linkage of individual-level eviction-filing and mortality records allows us to produce precise estimates of deaths averted due to eviction prevention policies. We also leverage natural experiments to examine the causal impact of these policies on county-level measures of mortality, capturing potential spillover effects. And our qualitative data help to clarify mechanisms underlying these impacts.

Public health relevance
Our project will estimate the impact of unprecedented pandemic era eviction-prevention policies on all cause- mortality, age-specific mortality, cause specific mortality, and differences in these outcomes by age, race and sex. We leverage: 1) a unique linkage between eviction filing data and mortality data to examine the impact of eviction on death rates during the pandemic 2) policy mapping data that comprehensively describes state and local eviction moratoria, data from the Treasury Department on the roll-out of emergency rental assistance, and a difference-and-difference framework to examine the impact of eviction prevention policies on county- level measures of mortality 3) qualitative data to examine lived experiences with these policies and pathways that connect them to mortality.